Cardiomyopathy Genomes Project

PROJECT SUMMARY
Cardiomyopathy is highly heritable, and cardiomyopathies are classified based on heart morphology with two
major forms being dilated and hypertrophic cardiomyopathy (DCM and HCM, respectively). In adult familial
cardiomyopathy, the most common form of inheritance is autosomal dominant with variable expressivity and
penetrance. Genetic testing now samples >80 genes and identifies a primary mutation in approximately half
the cases. With the same single mutation, there is considerable phenotypic variability. This is well seen in
families, where all members share the same primary mutation but with differing age of onset and expression.
The “missing heritability” for cardiomyopathy may be due to multiple factors, undiscovered primary or “driver”
gene mutations and/or an oligogenic genetic mechanism involving the interplay between driver variants and
the genomic context in which they are expressed. The genomic context for cardiomyopathy includes genetic
modifiers, which are not restricted to coding regions of the genome and likely includes noncoding genetic
variation. Genetic modifiers are defined as genetic variants that alter the phenotypic expression of a primary
mutation, and identifying these pathways is useful for clinical prognosis and to identify potential pathways
around which therapy can be developed. Historically, cardiomyopathy genetic investigations have been
restricted to a small fraction of the genome with limited information on the larger genomic signature of heart
failure. Whole genome sequencing (WGS) provides a more comprehensive picture of genomic context,
including both rare and common variation, that shapes the manifestation of driver variant(s) extending beyond
the coding region. In the prior funding interval, we generated and analyzed WGS data coupled with clinical
cardiac phenotype information from >300 individuals with cardiomyopathy. As a complement, we also now
have WGS data from >1000 individuals from Northwestern's NUgene Biobank, and these data are linked to
clinical data. Analysis of the cardiomyopathy genomes reveals variants in genes regulating cardiac energetics
and mitochondrial function as modifiers of HCM and DCM, as we will study this through mechanistic
approaches in model organisms and human cell models. We now propose to decipher complex
cardiomyopathy genetics by integrating WGS information, epigenetic signatures, and gene expression data.
Defining genetic modifiers for cardiomyopathy is expected to provide novel pathways contributing to heart
failure.

Public health relevance
PROJECT NARRATIVE Cardiomyopathy is characterized abnormal heart size and function, and genetic mutations cause multiple forms of cardiomyopathy within families. Genetic mutations causing cardiomyopathy are variably expressed from person to person, and genetic modifiers contribute to this variation. We are defining genetic modifiers for cardiomyopathy to help better diagnose risks and to define pathways that change the course of cardiomyopathy.